Genetics Association in Schizophrenia and Other Disorders

Project Description
In this application, we request extension of MERIT award R37MH057881, “Genetic Association in
Schizophrenia and Other Disorders”. In our previous aims, covering the last twenty years, we targeted
the development of statistical methods for identifying genetic variants affecting liability to mental
disorders. At each cycle we introduced novel statistical methods and evaluated existing methods to
extract association signal from genetic data. Here we propose to push the field forward again, but with a
different goal in mind: we plan to develop methods to understand how genetic variation influences
risk for mental disorders, what neurobiological mechanisms are perturbed, and how such variation
can be used to predict those at risk. Because we believe that a large portion of risk to mental disorders
is due to perturbation of gene expression and coexpression networks in specific cell types, our first aim
will be to develop models to describe tissueͲlevel and cellͲlevel transcriptomes and how they differ by
caseͲcontrol status. Next, we hypothesize that neurobiological mechanisms of risk can best be identified
by studying “communityͲlevel” behavior, which could be at the level of coexpressed risk genes or caseͲ
control differences in neural circuits connecting brain regions. Thus, in Aim 2, we will develop methods
to detect communities in static or dynamic systems and relate them to caseͲcontrol status. Finally we
believe a key to prevention of mental disorders is to first identifying those at risk. In Aim 3, we will
develop methods for prediction of risk that account for fineͲscale ancestry and relatedness on the
genomic level. We expect that Aims 1Ͳ2 will yield key insights into the etiology of mental disorders by
modeling core features that determine risk from the genetic and neurobiological perspectives, while
Aim 3 lays a foundation for prevention by improving prediction of those at risk. As has been true for our
last four funding periods, our theoretical work will be guided by real data from the evolving field of
human genetics and transcriptomics. We are well positioned to move between theory and data because
we have a diverse team of investigators lead by the PI (Devlin) and subcontract PI (Roeder) who have
decades of experience in the statistical genetics field.
4
What individuals will work on the project? Effort (monts) 3.6 2.4 1 6 1 6
Role PI CoͲinvestigator CoͲinvestigator Technician Technician Technician
Degree PhD PhD PhD PhD PhD PhD
DOB 10/1954 03/1959 11/1982
SSN 2807 1876 6455
Name Devlin, Bernie Roeder, Kathryn Lei, Jing Klei, Lambertus Doman, John TBH PostͲDoc
Key Yes Yes Yes No No No
Commons ID devlinbj roeder jinglei
5